Health Communications (HC)

PROJECT SUMMARY/ABSTRACT (HEALTH COMMUNICATIONS)
The Health Communications (HC) Shared Resource (SR) enables University of Michigan Comprehensive
Cancer Center (UMCCC) members to conduct state-of-the-science health communications research using a
range of innovative communication channels and technologies (e.g. internet/web, mobile, SMS/text, interactive
voice response) in diverse settings (e.g. community, clinic) across the continuum of cancer care. The HC SR is
comprised of an interdisciplinary team of behavioral and communication scientists, designers and graphic
artists, and technologists and programmers that work collaboratively to create user-centered interventions. The
Specific Aims of the HC SR are to 1) Support UMCCC members in the conduct of state-of-the-science health
communications research across the continuum of cancer care; 2) Apply health communications science to
advance the research enterprise in the UMCCC in areas such as the practice of precision oncology and
improving understanding and engagement in cancer clinical trials; and 3) Develop and deploy evidence-based
health communication interventions that engage communities, improve cancer prevention and control, and
reduce health disparities in the UMCCC catchment area.